R01 Upstream Approaches to Improve Late Life Care for People Living with Dementia

PROJECT SUMMARY
The long-term goal is to improve the quality of end-of-life care provided to families and people living with Alz-
heimer’s disease and its related dementias (dementia) by generating population-level evidence on the public
health impact of community-based support structures including skilled home health care. Alzheimer’s Disease
diagnosis in racial and ethnic minority populations is projected to more than double by 2030. Large racial and
ethnic differences and disparities exist in well-established end-of-life care quality indicators (inpatient admis-
sions, hospice use, place of death), and in people living with dementia some of these differences may be com-
pounded. One understudied approach to improving dementia care among racial/ethnic minority and socioeco-
nomically disadvantaged populations is the use of skilled home health care (a benefit under Medicare and
Medicaid). The short-term goal for this R01 is to define racial/ethnic differences in the effects of skilled home
health care on indicators of end-of-life care quality (e.g., inpatient admissions, use of hospice, and place of
death) as a function of dementia diagnosis. The central hypothesis is that “upstream” exposure to home health
care prior to and during the final year of life has a cumulative and beneficial effect on "downstream” end-of-life
care quality indicators: (1) inpatient admissions, (2) hospice utilization, and (3) place of death. The scientific
premise for this work is that PLwD have complex medical and behavioral health needs, and many rely on fam-
ily caregivers to help with activities of daily living and coordination of medical care. Too few benefit from skilled
home health care. As cognitive function deteriorates from mild symptoms and behavioral changes to more ad-
vanced illness, skilled home health care may help prevent avoidable hospitalizations, and minimize burden-
some transitions across care settings at the end-of-life. The central hypothesis will be tested by pursing three
specific aims: Examine the relationship between receiving skilled home health care prior to and during the last
year of life and: 1) inpatient admissions (type, frequency and length) in the last year of life, 2) hospice utiliza-
tion (timing and setting) in the last year of life, and 3) place of death (e.g., hospital, home, hospice in a hospital,
hospice at home). The aims will be tested using linked Medicare data sets to examine the effect of skilled
home health care utilization on racial and ethnic disparities in end-of-life outcomes among people diagnosed
with dementia compared to people not diagnosed with dementia. The research proposed in this application is
innovative, in the applicant’s opinion, because it focuses on evaluating an underutilized core benefit of Medi-
care through evaluating the effect of skilled home health care access on disparities in dementia care quality.
Successful completion of proposal aims will have a sustained and powerful impact by providing needed and
actionable evidence to reduce disparities in care for racial and ethnic minority older adults living with dementia.
The project will significantly impact the design, development, and evaluation of population health system inter-
ventions to eliminate or reduce disparities in care and end-of-life outcomes among people living with dementia.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on actionable evidence to improve national efforts focused on reducing disparities in care for racial and ethnic minority older adults living with dementia. Once such strategies have been developed, there is the potential for a significant advance in population health system interventions to reduce disparities in end-of-life outcomes among people living with dementia. Thus, the proposed research is relevant to the National Institute of Minority Health and Health Disparities (NIMHD) priority area regarding the role of access to care among health disparity populations and quality of care related to Alzheimer’s Disease and its Related Dementias diagnosis, treatment, and health disparities.